Increasing Access to Genetic Testing in Underserved Patients Using a Multilingual Conversational Agent

The volume of patients who meet national criteria for germline genetic testing based on a cancer diagnosis alone, regardless of family history (i.e. ovarian, pancreatic, advanced prostate, etc.) is rapidly growing. Germline genetic test results can inform oncology and surgical treatment decisions, as well as early detection and prevention for the family. However, traditional pre- and post-test genetic counseling approaches may not be sufficient to meet the growing need. Additionally, traditional pre-test counseling may be a barrier, leading to decreased uptake, especially in those with advanced disease. Patients cared for in settings with limited or no genetic services, already face challenges in access to care. As such, innovative strategies to optimize genetic counseling approaches are needed. Relational Agents (RAs) are an effective means of automating health education and counseling, as well as overcoming literacy barriers in the use of information technologies. RAs, animated computer characters, simulate face-to-face conversation between a patient and a provider using verbal and nonverbal conversational behavior. Overall Goals. This study will develop an RA to communicate personalized pre-test genetic education to a cohort of cancer patients who meet established cancer-based genetic testing criteria across two clinical settings. We hypothesize that the use of an RA will increase the proportion of patients who receive genetic test results within 90 days of initiating cancer care, compared to usual care. Aim 1 is to develop an RA using a patient-driven approach. Aim 2 is to conduct a multisite randomized controlled trial of the RA to deliver pre-test education versus usual care to compare the proportion in each arm who receive genetic test results in 90 days at Los Angeles General Medical Center and University of Rochester Medical Center. Aim 3 is to understand the implementation context and identify facilitators and barriers to utilizing the RA in these clinical settings. Impact. Our deliverable will be patient-facing RA to deliver pre-test genetic education. This RA will be developed and evaluated in two distinct patient populations and clinic workflows, can be rapidly updated as practice evolves, and will ultimately be available on the internet for clinics and patients to utilize. If successful, this would be a novel, effective, and scalable means of providing genetics education that could improve patients’ decisional preparedness, knowledge, and satisfaction, ultimately leading to increased access. Understanding the implementation context and identifying facilitators and barriers to integrating a RA will increase sustainability and generalizability.

Public health relevance
Germline genetic testing can change a cancer patient’s treatment and how their family members are cared for, yet many patients are not able to access testing We will develop and evaluate whether an animated computer character, called a relational agent (RA), can be used to provide genetic education to help overcome access barriers at two clinical centers (including a low-resource safety-net hospital). We expect that our work will have a significant clinical impact, both increasing access to timely genetic testing for cancer patients, in cancer and more widely across disease domains.